PossinK, NIH, R01 Supplement P0568851 4/4/2023

PROJECT SUMMARY/ABSTRACT
Dementia causes substantial burdens for patients and caregivers, which were exacerbated by the COVID-19
pandemic. The current state of dementia care is inadequate to meet the needs of this growing, vulnerable
population. Scalable, effective, and person-centered dementia care models that are aligned with value-based
healthcare reforms are needed now. The Care Ecosystem is an accessible, remotely delivered team-based
dementia care model, designed to add value for patients, providers and payers in complex organizational and
reimbursement structures. Care is delivered via the phone and web by unlicensed Care Team Navigators, who
are trained and supervised by a team of dementia specialists with nursing, social work, and pharmacy expertise.
Care Protocols guide proactive, quality care that is documented in the electronic health record. The evidence
base to date suggests that the Care Ecosystem improves outcomes important to people with dementia,
caregivers, and payers when delivered in a controlled research environment, including reduced emergency
department visits, reduced polypharmacy, higher quality of life for patients and lower caregiver depression. With
our parent project, we are conducting a rapid pragmatic trial in 6 health systems serving geographically and
culturally diverse populations. With this supplement, we will address unanticipated challenges in real time to
ensure that we complete the project as proposed, meeting enrollment targets and staying on our timeline. In Aim
1, we will bolster recruitment of Latino/Hispanic, Black/African American, and rural participants. In Aim 2 we will
expand our clinical teams so they can manage high needs patients, carry larger caseloads, and deliver the
medication care protocol with equity to all patients. In Aim 3, we will cover unanticipated expenses in accessing
and managing electronic health record data. This work will pave the way for expanding access to high quality
dementia care in the future, mitigating the negative impact of dementia on patients and their families across the
nation.

Public health relevance
PROJECT NARRATIVE The overarching goal of the parent R01 is to study the implementation strategies and effectiveness of the Care Ecosystem, a telemedicine supportive care intervention for persons living with dementia and caregivers, in 6 health systems during COVID-19. The supplement will bolster recruitment of Latino/Hispanic, Black/African American, and rural participants; expand our clinical teams; and allow us to effectively manage complex electronic health record data. With this supplement, we will be adequately powered to identify the effects of the Care Ecosystem on outcomes important to patients, caregivers, healthcare providers, and healthcare systems, and we will identify strategies that will facilitate successful implementation and sustainment.